VAST Center: Viromes Across Space(s) and Time

BIOSPECIMEN COLLECTION CORE ABSTRACT
The VAST Center Biospecimen Collection Core (BCC) will actively collect, process, and store samples across
the human lifespan, using innovative cross-validated Standard Operating Procedures (SOPs) for seamless
integration. Collaborating with the other cores, we will prioritize identifying and encrypting crucial metadata by
employing secure and ELSI-informed practices for data access, sharing, and reusability. We are uniquely
positioned to carry this out, with several pre-existing cohorts - including some that span up to 10 years - diverse
landscapes, and age groups; furthermore, our collection encompasses various populations, enabling a
comprehensive understanding of the virome. Led by internationally recognized experts, the BCC Core
collaborates closely with the ELSI core and PEDP to transparently address ethical concerns. Many cohorts will
contribute specimens immediately upon award, with potential for additional sample collection through prior IRB-
approved re-consenting. Aim 1 focuses on curating pre-existing specimens and metadata across 8 cohorts. The
Virome Characterization Center (VCC) aims to construct a central repository database for pre-existing samples,
serving the Biospecimen Analysis Core and Data Analysis Core, facilitating sample sharing. The VCC, with
immediate access to well-characterized samples from diverse cohorts, is uniquely positioned for biospecimen
analysis, including iPOP, Astronaut, Antarctica Travelers, Native American, African American & African, Kids
Camp, Newborn, and Airborne Exposure cohorts. Rigorous recontact and reconsent mechanisms have been
developed and are in alignment with the most rigorous ELSI standards. Aim 2 actively develops SOPs for future
biospecimen collection, prioritizing plasma and stool. Sub-aims include defining biospecimen type, volume,
source, frequency, and sampling approach; standardizing and harmonizing collection within and across cohorts;
ensuring rigor in biospecimen and data collection and storage; developing optimal sample collection strategies
for understudied body sites; and completing sample collection based on optimal procedures and size estimation.
Aim 3 emphasizes maximizing informed consent breadth. With a proven track record, exemplified in the iPOP
and Native American studies, we collaborate closely with communities to design ethical consent forms, ensuring
timely sample and data sharing, aligning with the Human Virome Program's objectives. Our collaboration with
the ELSI core and institutional review boards underscores our commitment to participant privacy, autonomy, and
ethical virome characterization. In summary, our active approach, cross-validated SOPs, and ethical practices
uniquely position our core to significantly contribute to the goals of the HVP.